OPTimizing surveillance in lung cancer survivors with novel IMAging biomarkers and deep-Learning (OPTIMAL)

ABSTRACT
Over the next decade, the number of lung cancer survivors is expected to rise considerably in the United States,
due to an aging and growing population and a shift toward more early-stage lung cancers detected from
increased lung cancer screening uptake. After treatment with curative-intent surgery, however, many survivors
of early-stage non-small cell lung cancer (NSCLC) remain at high risk for lung cancer recurrence or second
primary lung cancer (SPLC). To detect recurrence and SPLC at their earliest stages, postoperative imaging
surveillance with chest computed tomography (CT) is generally recommended every six months for the first two
years and annually thereafter. Yet, this clinical recommendation is based on limited evidence of benefits and
harms, with no consideration for individual differences in risk of recurrence or SPLC. Routine chest CT images
are a potentially useful, but largely untapped, data source for predicting risk of recurrence or SPLC to tailor
surveillance among lung cancer survivors. Chest CT scans contain specific imaging biomarkers of body
composition and cardiopulmonary health, as well as non-specific imaging data that are amenable to analysis
using deep learning, all ascertainable without additional intervention, risks, or costs to survivors. Studies
including ours suggest that skeletal muscle and adipose tissue measured from CT scans can predict outcomes
after NSCLC resection. In the context of lung cancer screening, we have also developed Sybil, a validated deep-
learning model that uses information from a single low-dose chest CT scan, to accurately predict future incident
lung cancer risk. Our overarching goal is to optimize survivorship of early-stage NSCLC following curative-intent
surgery by incorporating a risk-based surveillance strategy that leverages routinely available imaging data. Our
multidisciplinary team proposes to examine 12,000 individuals treated surgically for stage I or II NSCLC from
2015 to 2025, with follow-up for outcomes through 2027, using longitudinal electronic health records and serial
chest CT scans from three healthcare systems that serve distinct and diverse populations. First, we will
determine real-world practice patterns and effectiveness of imaging surveillance, overall and by individual
characteristics. Second, we will develop and validate risk prediction models for lung cancer recurrence and SPLC
that incorporate imaging biomarkers of body composition and of vascular and pulmonary health derived from
preoperative and postoperative surveillance CT scans. Lastly, we will assess and then optimize Sybil’s
performance in predicting lung cancer recurrence or SPLC using postoperative surveillance CT scans. Overall,
the proposed study will advance knowledge about the promising potential for personalized risk-stratified
surveillance of recurrent or new disease using novel imaging-driven methods among the growing population of
lung cancer survivors.

Public health relevance
PROJECT NARRATIVE The proposed study will comprehensively evaluate patterns of imaging surveillance, characterize the benefits and harms of imaging surveillance, develop and validate risk prediction models that incorporate imaging biomarkers, and adapt a deep learning model to predict subsequent risk for lung cancer recurrence or SPLC using CT images in lung cancer survivors. These results have the potential to inform patient and clinician shared decision-making conversations to guide individualized surveillance strategies. As the number of lung cancer survivors rises due to increased growth, aging, and the detection of early-stage lung cancer with screening uptake, this research is timely and responsive to the National Cancer Institute’s goal to identify optimal evidence-based schedules for surveillance of recurrence and progression and to generate better estimates of risk and potential benefit for surveillance practices.